Randomized study of low versus moderate dose busulfan in transplant for severe combined immunodeficiency

Project Summary
Severe combined immunodeficiency (SCID) is a group of genetic disorders that abrogate T cell
development and function. Allogeneic hematopoietic cell transplantation (HCT) is the standard treatment, for
the disease, which is typically fatal by age 2 years if not treated. HCT can be performed successfully in SCID
patients without the high dose pre-HCT busulfan conditioning typically used, due to the lack of functional T
cells. Despite restoration of T cell function, humoral immunity remains poor in many patients post-HCT. This
project seeks to test the efficacy and safety of a regimen of low dose, individualized targeted busulfan
compared to moderate dose in SCID patients at risk of poor humoral outcome undergoing non-matched sibling
donor HCT. We will target patients without active infection, leveraging the widespread implementation of
universal newborn screening in the United States. We hypothesize that in our proposed multi-institutional
randomized phase II trial patients receiving low dose busulfan will achieve similar outcomes compared to those
receiving moderate dose (myeloablative) busulfan, achieving both T and B cell immune reconstitution.
In Aim 1, we will examine immunological and safety outcomes in trial participants. Patients who lack
matched sibling donors, confirmed to have the appropriate genotype, and who do not have active infection will
be recruited over 4 1/2 years. Within each of 2 genotype cohorts (IL2RG/JAK3, RAG1/RAG2), 32 patients will
be randomized to cumulative area-under-the-curve exposure of busulfan of 30 mg*h/L versus 60 mg*h/L (32
patients per cohort, 64 patients total). IL2RG/JAK3 patients will also receive rATG and RAG1/RAG2 patients
will receive rATG, fludarabine, and thiotepa. Stem cell sources include unrelated and haploidentical related
donor products that will be TCRαβ+/CD19+ depleted with no post-HCT GVHD prophylaxis. The primary
endpoint is protective antibody response to tetanus, a gold standard of normal humoral immune function in
children, by 2 years post-HCT. Secondary endpoints include reconstitution of T cell number, thymic output, cell
type specific chimerism, response to live viral vaccines at 3 years, survival, and incidence of HCT related
complications.
In Aim 2, we will examine the correction of T and B cell abnormalities in depth. The central question is
whether mixed/split chimerism (donor-derived T cells with mixed chimerism in the B and myeloid
compartments) will nevertheless be associated with normal immune phenotype, function, repertoire and
tolerance in one or more genotypic cohorts. We hypothesize that generation of memory B cells, antibody-
secreting cells and correction of pre-existing abnormalities of the B cell receptor repertoire post-HCT will be
evident in all genotype cohorts and that the degree and quality of correction in the setting of mixed chimerism
will vary according to the biology of each genetic abnormality. We hypothesize that T cell exhaustion seen in
patients undergoing HCT in the absence of conditioning will be diminished or absent in trial participants due to
improvements in thymic output associated with engraftment of donor-derived HSC. We hypothesize that T cell
tolerance will occur by different mechanisms (central deletion versus peripheral regulation) according to donor
type (haploidentical versus well matched unrelated donor) yet will be induced successfully in patients with
mixed chimerism.

Public health relevance
Project Narrative Babies with severe combined immunodeficiency (SCID), a genetic disorder resulting in absence of T lymphocytes, die of infection by 2 years of age unless treatment with blood or bone marrow transplant is performed. This study will test whether transplantation with a low dose chemotherapy regimen will normalize the immune system of patients with common genetic subtypes of SCID identified at birth safely and effectively, avoiding the toxicity of high dose regimens currently in use. Results of this study can set a new standard for treatment of infants with SCID identified at birth, such that in the future, all babies with this otherwise fatal disease may live normal lives.